Exercise pressor reflex in peripheral artery disease: beneficial effects of heating and mechanisms

PROJECT SUMMARY ABSTRACT
Peripheral artery disease (PAD) is atherosclerotic disease with a decrease in blood flow to the arteries of the
lower extremities. Exaggerated sympathetic nerve activity (SNA) and blood pressure (BP) are observed during
intense exercise activity in this disease and these responses worsen exercise tolerance. The major goal of this
proposal is to examine if heat exposure and heat treatment have beneficial effects on PAD. We will explore this
clinically relevant hypothesis via examining the following specific aims utilizing both animal and human studies.
1. To examine the effects of heat exposure (i.e. whole body heating or local heating) on the exercise
pressor reflex (EPR). We hypothesize that heat exposure attenuates amplified EPR in PAD. In human studies,
muscle sympathetic nerve activity (MSNA) and BP responses to exercise will be examined during whole body
heating or local muscle heating in PAD patients and healthy control subjects. We speculate that MSNA and BP
responses will be accentuated in PAD patients as compared with healthy controls and these augmented
responses will be significantly attenuated by heat exposure. In animal studies, renal SNA and BP responses to
static muscle contraction will be examined in PAD rats and in control rats. We speculate that EPR will be
enhanced in PAD rats and increasing muscle temperature by heat exposure will attenuate the amplified reflex.
2. To examine the engagement of temperature-sensitive P2X receptors in the effects of heat exposure
on the EPR. We hypothesize that heat exposure decreases the levels of ATP in the muscle insterstitium and
thereby attenuates amplification of the EPR in PAD. In animal studies, we speculate that heat exposure will
attenuate the levels of interstitial ATP to a greater degree in PAD rats than in control rats. We further speculate
that P2X subtype (i.e., P2X3) will play a role in regulating the EPR in PAD after heat exposure.
3. To examine the effects of heat treatment (i.e. a prior heat exposure) on BP response during walking in
PAD patients and further to examine potential P2X mechanisms using animal studies. After a heat
treatment, walking ability in PAD patients will be estimated on a treadmill with a Gardner protocol. We speculate
that the BP response will be lower and the skeletal muscle oxygenation (SmO2) level will be higher than those
without the heat treatment at the same stage of the walk protocol. Moreover, the heat treatment may increase
peak treadmill walking time. In animal studies, we hypothesize that heat treatment attenuates expression,
function and response of P2X3 in PAD. We will examine the protein expression levels of P2X3 in muscle afferent
nerves of PAD rats. We speculate that heat treatment will decrease P2X3 in PAD rats. We further speculate that
heat treatment will attenuate the amplification of P2X3 current amplitude in sensory neurons innervating muscle
afferents in PAD rats and this thereby inhibits the exaggerated EPR.

Public health relevance
PROJECT NARRATIVE Cardiovascular disorders are common and lethal and have become an important issue in the U.S. The proposed studies in this application are designed to examine the role played by heat exposure and heat treatment in improving sympathetic and cardiovascular responses to exercise in peripheral artery disease. We will study the receptor mechanisms by which heat exposure evokes its effects. We will also examine the role played by heat treatment in attenuating the exaggerated sympathetic responsiveness observed in peripheral artery disease and thereby leading to enhancement of walking ability in this disease.